Investigating non-apoptotic cell death in glioblastoma

Summary
Glioblastoma (GBM) is the most frequent and deadly primary brain tumor in adults; the median survival of
patients with GBM remains a dismal 14-16 months. Resistance to apoptosis contributes to the dire outcome of
patients with GBM. However, whether GBM tumors are susceptible to non-apoptotic forms of cell death remains
largely unexplored. In new preliminary data, a library of molecularly and metabolically characterized patient-
derived glioma models was interrogated for sensitivity to non-apoptotic cell death. This analysis demonstrates
that GBM are extremely sensitive to inducers of a newly described form of non-canonical cell death that is
dependent on the lipid palmitate and altered protein palmitoylation. This novel form of cell death is referred to as
palmoptosis. Intriguingly, GBMs most susceptible to palmoptosis are enriched with specific molecular and
metabolic characteristics consistent with a proneural subtype, suggesting a unique subset of GBM may be
particularly vulnerable to tumor cell death mediated by palmoptosis. With a clinical drug available, these
preliminary findings support the proposed aims which will define the mechanistic basis for GBM palmoptosis
sensitivity and evaluate the therapeutic potential of targeting palmoptosis in clinically relevant GBM model
systems. In Aim 1, the relationship between specific molecular and lipid metabolic features that render GBM
susceptible to palmoptosis will be explored. Aim 2 investigates the role of protein palmitoylation in triggering
GBM sensitivity to palmoptosis. Finally, Aim 3 will evaluate whether apoptosis-resistant models of GBM, which
include in vivo models of recurrent GBM, are vulnerable to palmoptosis. Together, the proposed studies will
provide the first investigation into whether a novel, non-canonical form of cell death can be exploited in GBM.

Public health relevance
PROJECT NARRATIVE Glioblastoma (GBM) tumors are resistant to therapy-induced apoptosis, exposing an unmet need for alternative means to trigger GBM cell death. Herein we propose to explore the underlying molecular and metabolic underpinnings of GBM sensitivity to a new, lipid-mediated form of non-apoptotic cell death called palmoptosis. The results obtained from this proposal could pave the way for a new therapeutic approach to drive GBM cell death.